Administrative Core

The Harvard/UCSF ROBIN Center will address molecular mechanisms of radiation response and resistance
in childhood cancers, using the “quieter” genome of pediatric malignancies to identify radiation resistance
mechanisms that are broadly applicable to adult and pediatric patients. The Center consists of a Molecular
Characterization Trial, two Research Projects, two supporting Cores [one focused on Data Science and
Advanced Dosimetry and the second on Imaging and Artificial Intelligence (AI)] as well as the critical Cross-
Training Core (ROBIN-NEST). Collectively, these ROBIN Center components can be conceptualized as
either “Scientific” or “Programmatic” in nature.
Against this backdrop, this Administrative Core has two broad goals. Firstly, as the ROBIN Center’s
“inward looking face”, the Administrative Core will support the Scientific and Programmatic missions. Secondly,
the Administrative Core will serve as the “outward face” of the Harvard/UCSF Center and as point of contact
with NCI, other ROBIN Centers, diverse learners, the radiation sciences workforce, and the lay public. The
Administrative Core has three Specific Aims.
Aim 1 (Scientific Support): The Administrative Core will implement electronic communication
methods to facilitate transfer of accounting information, access to Research and Technology Management
forms, access to clinical research databases, and access to cloud-based data and code sharing platforms.
Aim 2 (Programmatic Support): The Core will integrate the Harvard/UCSF sites and unify the Center
via videoconferencing, in-person meetings, and online communication. Together with the ROBIN-NEST, the
Core will host an Annual Retreat to share and harmonize vision and logistics across the ROBIN Center. Finally,
the Core will request applications for, evaluate, award, and administer pilot and trans-Network Projects.
Aim 3 (NCI and Community Service): The Administrative Core will create the Harvard/UCSF
ROBIN Center’s website as a public-facing source of data and resources. Critically, the Core will also work to
strengthen the Harvard/UCSF Center with proactive strategies to enhance diversity of our research groups,
the radiation sciences workforce, communities served by our Center, and patients enrolled in our clinical trials.
Daphne Haas-Kogan, M.D. and Franziska Michor, Ph.D. will serve as co-leaders of the Administrative
Core and also as co-PIs of the Harvard/UCSF ROBIN itself. Each of the co-leads has extensive experience in
leading multi-investigator, multi-institutional research initiatives. Dr. Haas-Kogan is the Chair of the Department
of Radiation Oncology at Dana-Farber Cancer Institute (DFCI), Brigham and Women’s Hospital, and Boston
Children’s Hospital, and Dr. Michor has led two iterations of NCI’s Physical Sciences Oncology Network’s
(PSON) U54 initiative and also leads the DFCI Physical Sciences Oncology Center (DFCI PSOC). Drs. Haas-
Kogan and Michor will be assisted by Simon Maisel, MS, who will report directly to the co-PIs.